Vestibular contribution to the control of human upright stance

Project Summary/Abstract The long-term goals of this project are to understand how motion information from the inner-ear balance sensors of the vestibular system contributes to the control of balance in humans and to determine the extent to which galvanic vestibular stimulation (GVS) can be used to restore a useful vestibular contribution to balance in subjects with diminished vestibular function. GVS has long been used to demonstrate qualitatively a vestibular contribution to balance control, but a detailed quantitative understanding is lacking. Engineering system-identification methods and modeling will be applied to develop GVS as a quantitative tool for investigating the vestibular contribution to balance control and as a potential prosthetic aid to enhance balance in subjects with vestibular deficits. The proposed work has three specific aims. The first aim will combine experimental and modeling methods to: (1) define how motion information from vestibular sensors contributes to balance control, (2) determine how vestibular orientation information is combined with information from proprioceptive, somatosensory, and visual systems, (3) determine how combined sensory information is used to generate corrective responses to external perturbations imposed on a multi-segmental body, and (4) identify how subjects with bilateral vestibular loss (BVL) compensate for their vestibular loss. Models developed in the first aim provide quantitative hypotheses about mechanisms controlling balance. The second aim will use results from GVS tests to identify aspects of GVS-evoked body sway that differ from sway expected from the natural activation of vestibular receptors by actual head motion. We will develop a method that accounts for these differences, and then use GVS to test whether our model-based hypotheses of multi-segmental balance control predict how the vestibular contribution to balance control changes as a function of environmental and stimulus conditions. The third aim will use the identified characteristics of GVS-evoked balance responses and a model-based understanding of the balance control system to develop a method that uses GVS feedback, based on real-time measures of head motion, to manipulate the vestibular contribution to balance control. Because many BVL subjects remain sensitive to GVS, the potential exists for real-time GVS feedback to restore a functionally useful vestibular contribution to balance control in BVL subjects. Successful completion of the proposed experiments will provide new insights into the vestibular contribution to human balance control and mechanisms that compensate for vestibular loss. The development of methods for accurately manipulating vestibular-motion information using GVS feedback will facilitate future investigations of the vestibular contribution to motor tasks and could potentially contribute to the development of a vestibular prosthesis.

Public health relevance
Project Narrative Balance disorders leave a subject vulnerable to falls and the increased morbidity and mortality associated with falling. The proposed research will provide a greater understanding about how the nervous system uses orientation information from the inner ear's vestibular sensors for balance control, will determine what limits vestibular compensation, and will investigate a method for restoring some level of vestibular control of balance in subjects with deficient vestibular function. __SpecificAimsTextDelimiter__ Specific Aims The long-term goals of our research are to better understand how humans use orientation information from multiple sensory systems to control balance in challenging environments and how the nervous system compensates for sensory deficits that compromise balance. The focus of this proposal is on the vestibular contribution to balance control. Subjects with vestibular deficits are particularly vulnerable to falls in conditions in which orientation cues from other sensory sources (e.g., vision, proprioception) are limited. Recent evidence indicating that vestibular deficits are quite common, particularly in aging populations, supports the significance of research aimed at understanding the vestibular contribution to balance. Achieving an understanding of the vestibular contribution to balance is problematic because any natural perturbation to balance that stimulates the vestibular system simultaneously stimulates other sensory systems. To distinguish the vestibular contribution to balance from other sensory contributions, the proposed Aims 1 and 2 will: 1) develop mathematical models to account for multi-body segment, multi-sensory contributions to balance control, 2) use these models to interpret experimental responses to natural-balance perturbations, 3) identify changes in balance attributable to bilateral vestibular loss (BVL), and 4) use galvanic vestibular stimulation (GVS) to stimulate the vestibular system directly and test predictions from our multi-segment, multi- sensory balance control models. We will use results from Aims 1 and 2 in our Aim 3 experiments, to develop GVS methods for enhancing the vestibular contribution to balance control in patients with vestibular deficits. AIM 1: TO CHARACTERIZE THE VESTIBULAR CONTRIBUTION TO HUMAN BALANCE CONTROL. In preliminary studies, in which stimulus-evoked body sway of subjects with normal sensory function was compared to body sway of BVL subjects, the BVL subjects showed a greatly reduced - but not absent - ability to adjust their balance control in order to compensate for surface-tilt perturbations of increasing amplitudes. In Exp. 1, we will use surface-tilt and visual-tilt perturbations of varying amplitudes to evoke anterior-posterior (AP) or medial- lateral (ML) sway. These data will be analyzed to determine the dynamic characteristics of multi-segment body sway in normal and BVL subjects. We will interpret results from Exp. 1 using multi-segment, multi-sensory balance control models: 1) to quantify how normal subjects use sensory orientation information for stance control, 2) to determine how BVL subjects alter their balance control to compensate for vestibular loss, and 3) to determine the extent that visual orientation cues can substitute for absent vestibular function. The AP and ML models developed in Exp. 1 represent quantitative hypotheses about mechanisms controlling balance. The ML model will be tested in Aim 2, and it will inform our development of methods that use GVS to manipulate the vestibular contribution to balance in Aim 3. AIM 2: TO DETERMINE THE INFLUENCE OF GVS ON NATURALLY OCCURRING VESTIBULAR SIGNALS THAT CONTRIBUTE TO BALANCE CONTROL. We hypothesize that the non-natural patterns of GVS-evoked vestibular signals produce a distorted estimate of head orientation that can be modeled by a "GVS filter". This GVS filter provides a quantitative representation of how the nervous system interprets and distorts head-orientation cues from the non-natural GVS activation of the vestibular system, in contrast to undistorted cues from the natural activation of the vestibular system. In Exp. 2, we will identify the properties of the GVS filter. Then, taking into consideration the GVS filter properties, we will apply GVS to test the ability of our newly developed ML model from Aim 1 to predict the multi-segmental body sway evoked by GVS. Any differences between the model predictions and experimental results will guide refinements of our model in order to obtain an accurate representation of the vestibular contribution to balance. AIM 3: TO DEVELOP METHODS THAT USE GVS TO MANIPULATE THE VESTIBULAR CONTRIBUTION TO BALANCE CONTROL. We hypothesize that real-time GVS feedback can enhance or restore the vestibular contribution to ML balance control in patients with vestibular deficits who still retain responsiveness to GVS. GVS feedback refers to the delivery of GVS, with its electrical current being a function of ML head-tilt measured in real-time and with the GVS corrected for the GVS filter properties identified in Aim 2. We will apply GVS feedback to normal subjects in experiments designed to cancel head-orientation cues provided by naturally occurring vestibular signals, thus nullifying the vestibular contribution to balance (Exp. 3). We will then apply GVS feedback to BVL subjects (Exp. 4), but in this case, we will be using the GVS feedback to restore a functional vestibular contribution to balance control in BVL subjects who are responsive to GVS. Results from our proposed research will help elucidate how the nervous system uses orientation information from vestibular sensors to maintain stable stance. We propose that elucidation of natural and GVS-evoked vestibular contributions to balance control will inform the design of a future vestibular prosthesis that can partially restore the vestibular contribution to balance in vestibular-deficient persons, thus reducing their falls in challenging environments that present conflicting orientation cues. In our proposed research, although we will test GVS-feedback in the extreme case of BVL subjects, the methods we develop will also benefit other persons with diminished vestibular function due to aging and disease.